OLIGODEOXYNUCLEOSIDE BORANOPHOSPHATES--NEW DNA ANALOG

DESCRIPTION: A new class of modified nucleic acids, the oligodeoxynucleoside boranophosphates (BH3-ODN), are isoelectronic and iso-ionic analogs of the phosphorothioates and the naturally occurring O-phosphate esters. Studies demonstrate that HB3-ODN possess unique properties and have potential for application as diagnostic and therapeutic agents. Relative to normal DNA, BH3--ODN have increased lipophilicity and are notably resistant to degradation by nucleases. Preliminary data suggest that BH3--ODN support RNAse H induced cleavage of RNA. BH3--ODN can by synthesized enzymatically to give gene-length fragments that are accurate, complementary copies of the parent DNA. A promising new chemical method for synthesizing BH3--ODN is currently being explored. Further applications are planned for solution phase chemistries to solid phase synthesis, making possible for the first time the synthesis of lon oligos with defined sequence, at up to millimolar scale. Other goals of the proposed work are to examine further the unique chemical and biological properties of the boranophosphate oligomers, and develop a novel set of boronated compounds for practical use. The specific aims are to: 1)Develop effective chemical and enzymatic approaches to expedite synthesis of the BH3--ODN of any given length and sequence, in conjunction with appropriate analytical methods to verify the BH3--ODN integrity, base composition, sequence, and length. 2)Investigate and delineate the chemical, biochemical, and biophysical properties of BH3--ODN which are most essential for biochemica and therapeutical applications, including their stability under physiological conditions, nuclease resistance, lipophilicity and ability to cross cell membranes, metabolism, and their ability to form duplexes and triplexes with the complementary DNA and RNA. 3)Examine the potential of BH3--ODN for activating RNAse H in vitro and for arresting translation and transcription. 4 Conjugate BH3--ODN with appropriate functional groups (peptides, phospholipids fluoresce labels, etc.) to facilitate their cell penetration and targeting to specific cell types, and to examine their cell localization. 5) Study the feasibility of employing BH3--ODN to target human viral and genetic diseases. Results will be compared with other modified ODN. Thus, boranophosphates represent and exciting new chemistry on which to build new diagnostic and therapeutic technologies.